Clinical Samples Core

Abstract
The Clinical Core is integral to our CCRC’s activities coordinating and overseeing the access and distribution
of biospecimens obtained from well characterized coccidioidomycosis patients to all investigators. This core will
also provide regulatory support and, when necessary, assistance with study design and statistical analysis.
This Core strengthens the coalition of expert clinical investigators with the fundamental aim of obtaining
biospecimens and comprehensive clinical data from subjects with coccidioidomycosis. Our program has
partnered with the two largest coccidioidomycosis clinical facilities in California: the Valley Fever Institute (VFI)
affiliated with the Kern County Medical System and located in Bakersfield, the epicenter of coccidioidomycosis
at the southern end of the California Central Valley; and the University of California Davis (UCD) Center of
Excellence in Valley Fever, located at the northern end of the Central Valley. These two centers, and the skilled
clinicians who run them, offer our program premier access to the key specimens and data needed to identify the
genetic and immunological causes of disseminated coccidioidomycosis (DCM). Coordinating patient samples
from two foremost institutions ensures a broadest variety of clinical phenotypes and diverse genomic ancestries
of the patients drawn from across the Central Valley of the state of California, and a major strength of this Core
is that the patient base we sample from will be among the largest and most diverse ever collected for
coccidioidomycosis.
We propose two straightforward aims in this core. First, in Aim 1, we will provide clinical samples and data.
Biospecimens include blood and bronchoalveolar lavage specimens. Samples will be coded to de-identify.
Phenotype information will be captured in an electronic clinical Case Report Form and stored in REDCap. This
Core will work with the Administrative core to ensure oversight over samples. In Aim 2, the Clinical Core will
ensure ethical approvals and human subjects approvals are all in place. Biosafety protocols for shipping and
handling diagnostic specimens from patients will be developed and followed.
The Clinical Core thus provides critical infrastructure and services for our research program to meet its goals
for all Projects requiring human specimens.